TREATMENT OF UROGENITAL ATROPHY WITH LOW DOSE VAGINAL ESTRADIOL

This study will examine whether low doses of vaginal estradiol exert only local effects on the vaginal and urethral mucosa without systemic absorption of estradiol; so that symptoms of urogenital atrophy are improved without side effects of systemic therapy (i.e. potential risk of breast cancer). Twenty-five postmenopausal women with urogenital atrophy will be studied, 5 in each cohort. The five cohorts will be as follows: 10 mcg, 5 mcg, 2.5 mcg and 1.25 mcg doses and placebo.